UF PASS: Regulation of exercise transducers: supplement for diverse students

Abstract: The purpose of this Research Supplement is to Promote Diversity in Health-Related Research through support of the career development training for Bryan Alava, a current PhD student at the University of Florida. This administrative supplement will facilitate career development for the candidate and as well as contribute to the mission of the parent project - to discover novel exercise induced health related outcomes. The parent award is part of the MoTrPAC consortium that combines well defined exercise interventions with multi-omics analysis to develop a map of molecular transducers that link exercise to systemic health. To date, the consortium is analyzing the multi-omics data across 17 different tissues collected following a defined treadmill exercise paradigm as part of the preclinical studies. The primary objectives of Mr. Alava’s proposed research are two-fold: First to use a defined Alzheimer’s Disease (AD) mouse model to characterize changes in skeletal muscle function and blood markers of inflammation and metabolism. Second, once characterized we will use this model to test a treadmill training protocol, based on the protocol used for MoTrPAC, for efficacy in delaying the progression of AD. We will also be in a position to access the larger multiomics data available from MoTrPAC to expand potential molecular targets of exercise and AD pathology. Dr. Esser, the PI of the U01, will be one of two primary mentors for Mr. Alava. Dr. Jose Abisambra is the other co-mentor as his lab provides the AD mouse model and expertise in the analysis of brain pathologies. Drs. Esser and Abisambra are already official co-mentors for Bryan Alava within the Ph.D. program in the Department of Physiology and Functional Genomics within the College of Medicine at the University of Florida. We have outlined a series of didactic and experiential training activities that will equip Mr. Alava with the necessary skills to progress as an independent scientist and to fulfill the NIH mission to advance the careers of a diverse population of scientists.

Public health relevance
Narrative: The purpose of this application is to provide support for the career development training of Bryan Alava, a current PhD student at the University of Florida. This administrative supplement will facilitate career development for the candidate and as well as contribute to the mission of the parent project - to discover novel exercise induced health related outcomes.